Pilot Project Core

PROJECT SUMMARY
PILOT PROJECT CORE
The Developmental Exposure Alcohol Research Center (DEARC) includes a Pilot Project Core (PPC). The
goals of the PPC are to (i) provide a structured funding mechanism to seed the development of new ideas,
collaborative teams or technical approaches relevant to the central themes of the DEARC; (ii) support career
growth for both young and seasoned investigators, particularly those from historically under-represented
groups, through mentoring and facilitated collaboration; and (iii) capitalize on unique and timely opportunities
that may arise from the rapidly changing, dynamic field of research on alcohol and development. The PPC will
achieve these goals through administration of a Pilot Project program that solicits Pilot Project Proposals from
eligible investigators, coordinates the review process for proposals received, and ultimately oversees the
award and reporting functions for all supported Pilot Projects. In addition, the PPC will help promote scientific
connections among new members of the DEARC, and between these new members and established DEARC
investigators to further increase scientific synergy and promote both peer-based and mentor-mentee
relationships within the Center. Pilot Projects will be supported for 1-2 years each and will be funded at $45K
(direct costs) per year. Using this approach, we will support at least 6 funded pilot projects during the proposed
5-year funding period. Two highly innovative Pilot Project proposals are proposed to begin in the first budget
year of this Center. The first pilot project (PI: A. Gano) seeks to examine the transcriptomic effects of a unique
and innovative “double hit” model that examines the additive or interactive effects of prenatal and/or adolescent
ethanol exposure. It will use RNAseq and rtPCR to determine genes and gene networks that are differentially
expressed as a function of ethanol exposure during these two key developmental stages. The second pilot
project (PI: E. Galaj) will test the hypothesis that adolescent intermittent ethanol exposure leads to impaired
conditioned reinforcement learning by dysregulating activity of brainstem cholinergic inputs to the ventral
tegmental area; it will use a combination of optogenetic, fiber photometry and behavioral methods. Future
projects will similarly promote the scientific objectives of the DEARC through novel technical and conceptual
advances. Through support of exciting new projects and investigators, novel collaborative ventures and
technology development efforts, the PPC will serve as an incubator of great new ideas and teams that will
positively contribute to the mission of the DEARC.